Long DNA Assembly on Electronic Nanochannel Chip Devices

The long-term objective of this research program is to greatly increase the availability of large DNA constructs
for biomedical researchers, by providing a new, highly automated, and low-cost way of making long synthetic
DNA molecules. Gene-length DNA is routinely used by genetic engineers to deliver narrow functionalities into
engineered cells. Long DNA—which may comprise 10’s, 100’s or even 1000’s of genes—can deliver far more
complex functionality into cells, such as installing entire chemical synthetic pathways into bacteria to produce
valuable drugs, or delivering larger recognition and killing payloads into immune cells being programmed to
target cancer cells, or having far more viruses and strains represented in mRNA vaccines, which are normally
single gene-based. For optimal scaling and economics, these future long DNA assembly chips would be the
same type of chip that are mass produced for processors, memory, imaging, and communications, so-called
“CMOS chips”. The scaling properties of such chips have been transformative for the industries they touch and
can do the same for production of designer long DNA. CMOS chip devices offer the greatest potential for
miniaturization, precision automation, and low-cost deployment, far beyond what is possible with the robotic
automation that is currently used in industrial biofoundries that make custom DNA. The specific approach that
enables the construction of long DNA in a way that will map ideally onto future electronic CMOS chips is to use
all-electronic control of DNA motion within nanoscale channels, to route around and join the small building block
pieces of DNA. Towards this goal, one Aim of this project is to develop precision motion control for DNA
fragments moving in the channels. The other Aim is to use this motion control to bring together and join distinct
DNA fragments. The methods of this project will consist of fabricating discrete electronic nanochannel devices
and using these to explore all relevant motion control parameters. Issues of biocompatibility and biofouling of
will also be considered, in the context supporting the desired DNA assembly workflow. The findings from this
project will directly enable the next phase to fabricate a CMOS chip device, towards the ultimate goal of
dramatically increasing access to long DNA for more powerful genetic engineering in biomedical applications.

Public health relevance
The goal of this project is to greatly increase the industrial capability for making large pieces of DNA, to empower genetic engineers with much bigger DNA payloads to put into cells. Large pieces of DNA, containing many genes, could be used to program bacteria with entire production processes to make valuable drugs, or to program immune cells with much more capabilities to detect and kill cancer cells, or to create much larger payloads for mRNA vaccines, beyond one gene, to cover multiple viruses and strains. Therefore, by providing methods of making such large DNA economical and readily available to researchers, this project can have broad impact across all such areas of health where genetic engineering plays a direct or supporting role.